Cytoplasmic Organization by phase transitions

Project Summary/Abstract (PI Gladfelter, AS)
Cells must compartmentalize biochemistry in time and space. A newly appreciated mechanism of organization
is biomolecular condensation. In many cases, condensates form via weak, multivalent interactions among
disordered proteins and nucleic acids. These interactions determine the material states of condensates such
as viscosity, surface tension and porosity, which in turn impact the concentrations, reaction and transport rates
in, out and within condensates of key constituents. There are major gaps in understanding how cells control
where condensates form, which molecules coassemble, and how condensate material state contributes to
function. We discovered a physiological function for condensates in controlling nuclear division and cell
polarity in the filamentous fungus, Ashbya gossypii. These condensates can control translation and are formed
by an RNA-binding protein called Whi3 binding to target RNAs important for nuclear division (cyclins) and cell
polarity (formins). The power of this cell system is that we can link physical properties and locations of
condensates to functional outputs of protein translation, cell shape and nuclear division. The goals of the
proposed work are to determine how structured elements in proteins, RNAs and cell membranes control the
material state, location and function of condensates in the cell. We will determine how nanometer scale
features of protein and RNA sequences promote mesoscale physical states of condensates to spatially pattern
protein translation. We use an interdisciplinary suite of advanced imaging, genetic, biophysical and modeling
approaches to tackle these fundamental open problems that not yet understood for any phase-separating
system. Specifically, we will: Aim 1: Determine roles of hidden structured domains of proteins. We
hypothesize that transiently ordered states promote specific protein-protein interactions and condensate
material properties. Aim 2. Establish the architecture and function of RNA-based scaffolds. We hypothesize
that mRNA forms a higher-order network using base-pairing that determines condensate properties. Aim 3:
Delineate how membrane platforms control condensate assemblies. We hypothesize that endomembranes
provide sites of assembly to specify the location of condensates. The proposed work will define how protein
structure, RNA scaffolds and cell membranes are harnessed to control the properties, functions and locations
of condensates in cells. The importance of condesates is underscored by numerous findings that link aberrant
formation of condensates to multiple human diseases, including cancer and neurodegenerative diseases.
While it is clear condensates undoubtably impact biochemistry, we do not yet understand how condensates
actually contribute to normal cell function which is critical to understand how their malfunction leads to human
pathologies.

Public health relevance
Project Narrative Many human diseases including neurodegerative disorders arise due to the formation of toxic aggregates that lead to cell death. The same properties of proteins that cause aggregation, however, are used by cells for normal functions such as cell growth and division. Our work addresses how cells regulate physiological, functional aggregates and avoid the assembly of toxic, pathological aggregates. !